Putting Data in Context to Mitigate Pediatric Inpatient Prescribing Errors

Prescribing errors are common in inpatient pediatrics, resulting in preventable harm to up to 6000 US
children per year. These errors occur within 3 overlapping contexts: individuals susceptible to human error,
interprofessional teams susceptible to ineffective communication, and systems with inadequate safeguards.
However, our understanding of the incidence of prescribing errors and the contribution of these contextual factors
is limited because neither prescribing errors nor their contextual factors have been reliably measured or
assessed at scale.
Our central hypothesis is that adding novel context measures to traditional error prediction measures can
enable us to predict prescribing errors with high accuracy. Preliminary work by our group and others have built
algorithmic error identification tools using electronic health record (EHR) metadata and identified measures for
each of these contexts that are predictive of prescribing errors. Building on this work, this proposal aims to
validate the algorithmic approach to detecting pediatric prescribing errors at scale, validate the use of EHR
metadata to identify individual, team, and system contextual factors which predict errors, and develop a machine
learning model that can predict errors.
In the first aim, we will build upon existing wrong-patient order identification tools to validate a broad
algorithmic approach to detect pediatric prescribing errors, comparing algorithmic detection of prescribing errors
to gold-standard blinded expert prescription review.
In the second aim, we will validate the use of EHR metadata to measure team composition and
interactions through a comparative focused ethnographic research approach incorporating in-depth observations
and interview findings in relation to EHR metadata.
Finally, in the third aim we will evaluate individual, team, and system context factors in relation to
prescribing errors at three large children’s hospitals, using hierarchical logistic regression to quantify associations
and testing the ability of machine learning prediction models to predict prescribing errors using EHR metadata
with high accuracy.
Through these aims, we expect to identify novel approaches to measuring the inpatient pediatric context
and to develop a machine learning model incorporating relevant contextual factors to predict prescribing errors.
These findings will be readily generalizable, as they are based on ubiquitously-collected data, enabling a
multicenter trial of a transformational approach to clinical decision support, in which context factors inform real-
time feedback on high risk prescriptions to prescribers, pharmacists, and nurses caring for the most vulnerable
children.

Public health relevance
Prescribing errors are common in inpatient pediatrics, but are underreported and with poorly understood risk factors. The purpose of this research is to quantify prescribing errors and their related contextual factors using electronic health record metadata, thereby enabling machine learning models that can predict prescribing errors with high accuracy. This prediction modeling approach can then inform a new generation of clinical decision support systems that incorporate context factors to improve predictions and reduce patient safety threats.